Investigation of TNRC18 in Left-Right Patterning and Congenital Heart Disease

Project Summary/Abstract
Congenital Heart Disease (CHD) is the most prevalent birth defect affecting 1% of live births and is one the top
causes of infant mortality worldwide. Heterotaxy (HTX) is a severe form of CHD resulting from abnormal left-
right (LR) patterning during embryonic development. Heterotaxy is highly genetic, yet the complex genetic
underpinnings of this potentially life-threatening disorder remain poorly understood. Whole exome sequencing
of two siblings born with heterotaxy symptoms identified a novel CHD gene Trinucleotide Repeat Containing
Protein 18, TNRC18. TNRC18 is understudied with only one, recent study investigating its function. A
preliminary loss-of-function (LOF) screen in the high-throughput human disease model Xenopus resulted in
malformation of the cardiac outflow tract and LR patterning defects, recapitulating the patient phenotype. Thus,
the overall goal of this proposal is to elucidate the molecular mechanism by which abnormal TNRC18
leads defects in LR patterning and CHD/HTX. The first aim will use LOF experiments to determine the
earliest role of TNRC18 in LR patterning cascade by visualizing global pitx2c expression and dand5 expression
in the left-right organizer. Determination of spatiotemporal tnrc18 expression in early development in will focus
subsequent mechanistic analysis. The second aim will explore the functional significance of TNRC18 patient
variants and whether the BAH domain known to have significance for chromatin modification also impacts
development. Together, these experiments will elucidate the role of tnrc18 in left-right patterning, cardiac
development, and CHD pathogenesis. This will aid future patient diagnosis and outcomes as their treatment
can be targeted to genotype in addition to CHD phenotype. This application also outlines my (the applicant’s)
training plan in advanced coursework, research mentorship, new techniques, and professional skills including
written and oral data presentation. This training plan will equip me with the skills to pursue a career as an
independent physician-scientist.

Public health relevance
Project Narrative Congenital Heart Disease (CHD), or developmental malformation of the heart, affects around 1% of all live births and is among the major causes of infant death in the United States. In order to understand the underlying genetic and molecular mechanisms of heart development, we must study the roles genes found in genome wide association studies from these patients, such as TNRC18. This will allow us to better serve the needs of the patients and our unified search for cures and treatments to improve patient outcomes.